Heteromers and L-type calcium channels: Increasing the potency of emodepside in filarial nematode model, Brugia malayi

Project Summary
Filarial nematode infections are a global concern for public health. Lymphatic filariasis, caused by filarial
nematodes like Wucheria bancrofti, Brugia malayi, and Brugia timori, affect over 120 million people in
tropical countries of the world. Lymphatic filariases are not usually life-threatening, but people are often
ostracized from society due to distorted limbs and skin lesions. Control of these parasitic nematodes
depends significantly on the mass drug administration (MDA) of anthelmintic drugs: but there are no
effective macrofilaricides that kill the adult parasites in the host. There are concerns that mass drug
administration of microfilaricide chemotherapy will lead to the development of resistance. Emodepside is
an emerging anthelmintic that targets nematode large conductance potassium channels SLO-1 and is
the only drug that can kill adult filaria. Single dose emodepside treatments could allow a major advance
over existing MDA programs. However, the in vitro efficacy of emodepside varies between the different
filarial species, the sex, and the life cycle stages of the same parasite species. There is also a disconnect
between the in vivo and in vitro effect of emodepside on the SLO K channels. Here, we propose,
Aim #1: To characterize the pharmacology of endogenous SLO-1/2 channels. We will use erg-28
mutants in C. elegans to investigate the pharmacology of the endogenous SLO-1/2 receptors for
activation by emodepside. We will test for activation and potentiation of emodepside responses by other
BK channel agonists like Arachidonic acid and NS11021. We will parasitize C. elegans by expressing
Bma-slo-1 and Bma-slo-2 and assay the pharmacology of the endogenous filarial SLO-1/2 heteromer.
Aim #2: To test the hypothesis that EGL-19 channels modulate SLO-1 responses to emodepside.
We will knock down egl-19 in B. malayi and investigate the potency of emodepside inhibiting the motility
of these worms. We will also evaluate the role of EGL-19 agonists and antagonists in potentiating or
inhibiting the emodepside responses in worm motility. We will determine if EGL- 19 modulates SLO-1 in
microdomains using cell-attached patch-clamp experiments on Brugia muscle.
On completing these experiments, we will have enhanced insight into the pharmacology of the
endogenous SLO-1/2 heteromeric channels and aid the development of new and more effective
macrofilaricides. We will improve the efficacy of emodepside by using drug combinations that selectively
increase calcium in micro-domains close to SLO-1 channels. The use of combination therapy can
enhance the potency and efficacy of emodepside where bioavailability or activity against particular
nematodes species may be low.

Public health relevance
Project Narrative Parasitic nematode infections like lymphatic filariasis affect the health of over 200 million people in developing countries resulting in severe disfigurement (elephantiasis) and disability. In the absence of vaccines, current treatment solely depends on mass drug administration targeting the microfilariae. These drugs have no or very little effect on adult worms and have an ever-increasing concern for developing resistance. Emodepside is a new and the only drug that can kill adult filaria. Effect of emodepside on certain in vivo models shows a lack of adulticidal effects. Emodepside potency varies between in vitro and in vivo studies. Our study will highlight the role of endogenous SLO-1/2 heteromeric channels in modulating emodepside responses in vivo. We will also characterize the modulation of emodepside potency by activating an L-type calcium channel, EGL-19 present adjacent to SLO-1 channels. Combination therapy targeting EGL-19 and SLO-1 could provide a rational basis to improve emodepside potency in vivo.